Training Program in Basic and Translational Pediatric Oncology Research

PROJECT SUMMARY
Pediatric cancers are generally quite different than adult cancers. For example, pediatric cancers exhibit unique
oncogenic mechanisms, often reflective of aberrant developmental pathways. Thankfully, pediatric cancers are
rare, and so the field must rely more strongly on cooperation, collaboration, and team-science to enable scientific
progress and translation to the clinic. These realities, when combined with an insufficient research workforce,
necessitate the development of a specifically-designed training program for pediatric oncology research.
The overarching goal of the “Training Program in Basic and Translational Pediatric Oncology Research” is
to provide postdoctoral and graduate student trainees with the requisite skills and expertise to develop into
successful researchers focused on pediatric oncology. The Training Program is centered at the Abigail Wexner
Research Institute at Nationwide Children’s Hospital, a world-renowned pediatric research hospital environment,
and also leverages the strengths of The Ohio State University as an academic partner. Training includes strong
mentorship in laboratory-based basic and translational research with newly-developed program-specific
classwork, a broad palette of elective classwork, thoughtful training in career-development, team science, and
relationship-building, and a clinical exposure plan to enable trainees to better appreciate the impact of their work
on patients, families, and clinical teams.
This new application seeks 6 training slots per year: 3 postdoctoral fellows and 3 graduate students. Trainees
will generally spend 2 years in the Training Program. Postdoctoral trainees include Pediatric Heme/Onc/BMT
MD (or MD/PhD) fellows and PhD (or MD/PhD) postdoctoral trainees. Graduate students are drawn from one
of three graduate programs at The Ohio State University. A well-constructed trainee selection plan with a focus
on diversity will ensure that the trainees who enter the Training Program have a high-likelihood for success in
their ultimate entry into the field of pediatric cancer research.
Finally, the Training Program includes a thoughtful logic model as a framework for program evaluation and
continuous improvement cycles. The trainees, the mentors, and the Training Program itself will all be subjected
to rigorous evaluation by our External and Internal Advisory Boards, consisting of individuals with key areas of
expertise and focus, to ensure that the Training Program continues to evolve as training needs evolve.
Overall, the Training Program in Basic and Translational Pediatric Oncology Research will expand highly-
skilled pediatric oncology research and improve its collaborative potential to transform the care of children with
cancer.

Public health relevance
PROJECT NARRATIVE The “Training Program in Basic and Translational Pediatric Oncology Research” will create a cadre of well- trained researchers in pediatric cancer who communicate and collaborate broadly, partner with clinicians and clinical scientists, and help bring basic and translational science discoveries to the clinic to transform the care of pediatric cancer patients.